Structural investigations of coronavirus spike protein

PROJECT SUMMARY
The spike (S) protein decorates the surface of coronavirus (CoV) particles such as SARS-CoV-2 and enables
CoV's to enter and infect host cells. The S protein is the immunogen in genetic and subunit vaccines against
COVID-19, which were critical in controlling the COVID-19 global pandemic. In cells that are infected with CoV's
or have received a genetic vaccine, the S protein is synthesized in the mammalian cell endoplasmic reticulum
(ER), and then trafficking via the secretory pathway consisting of ER, Golgi network, and plasma membrane
(PM). This secretory trafficking of S is bidirectional between ER and Golgi, which are the secretory organelles
that provide the enzymatic machinery for post-translational modifications, remodeling, and maturation. This
includes enzymes for N-glycosylation, which modulates S folding, viral entry, and interactions with the host
immune system. Structure-function investigations have shown that N-glycans modulate conformations of S
domains, such as the immunogenic receptor binding domain (RBD). Therefore, S N-glycans play a direct role in
immune response modulation. As such, N-glycan maturation changes in S due to tissue-, population-, ethnicity-
, and age-specific differences in biosynthetic machinery have the potential to dramatically alter infection CoV
outcomes and genetic vaccine immunogenicity. Yet little is known about the atomic-level consequences of N-
glycan maturation on S structure-function. This is mainly due to the inability to arrest S in various stages of
trafficking and N-glycan maturation. In this grant application, we will use an innovative new methodology to
control S trafficking. Purified samples of these novel S constructs will be structurally characterized using latest
cryoEM and computational tools and assayed for interactions with highly potent conformation-sensitive
antibodies. This will generate unprecedented and the first insights into structural modulation of S conformations
and epitopes by N-glycan maturation. Collectively, these investigations will be highly significant in providing
fundamental insights into secretory trafficking and the role of bidirectional trafficking of S in modulating N-glycan
maturation and RBD conformations. These data will open avenues for the design of a new generation of S-based
vaccines with improved immunogenicity. In the future, the insights from this research will serve as a platform to
inform the design of vaccines against enveloped viruses that pose global health challenges such as HIV and
influenza, which utilize the host cell ER-Golgi-PM secretory pathway to acquire immunity evading glycans.

Public health relevance
PROJECT NARRATIVE The biogenesis of the immunogenic SARS-CoV-2 spike (S) protein involves its trafficking between endoplasmic reticulum, Golgi network, and plasma membrane (PM), which provide the enzymatic machinery for post- translational modifications, remodeling, and maturation including of N-glycans that modulate S immunogenicity. Atomic-level insights into how S trafficking modulates N-glycan maturation and subsequent interactions with the immune system will substantially enhance our understanding of COVID-19 infection mechanism, genetic vaccine design, and provide a platform to understand the fundamental principles of viral glycoprotein biogenesis. The investigations proposed in this grant will employ structural, computational, and biophysical tools to generate atomic level details underlying the modulation of S conformations and epitope exposure by N-glycans, thus providing new approaches to vaccine design against existing and emerging coronaviruses.